The Effect of a Desensitization Protocol in Highly Sensitized Renal Transplant Recipients on T Follicular Helper Cells

PROJECT SUMMARY/ABSTRACT
Title:
The Effect of a Desensitization Protocol in Highly Sensitized Renal Transplant Recipients on T
Follicular Helper Cells
Abstract:
Kidney transplantation is the definitive and preferred treatment for end-stage renal disease given it is
superior in cost, outcomes, complications, and patient satisfaction compared to hemodialysis. Long-term
transplant success is limited by antibody formation and associated antibody-mediated rejection (AMR).
Individuals with antibodies against a broad group of donors are considered “highly-sensitized” individuals.
Highly-sensitized individuals have a smaller pool of potential donors and experience worse outcomes.
Strategies to transplant these individuals, such as desensitization, have so far been unsuccessful. We
need to better understand how antibodies are formed and develop strategies to prevent antibody formation
and rejection.
T follicular helper (Tfh) cells are known to be essential to antibody formation. A particular subset of
Tfh cells, Tfh2 & Tfh17, are thought to be responsible for production of the complement-fixing IgG and IgM
antibodies that are required for AMR. It is unknown what role Tfh2 & Tfh17 play in the process of
sensitization and their response to desensitization. I hypothesize that Tfh2 & Tfh17 are a) predictive of
DSA development and graft rejection in the sensitized individual, and b) reconstitution of these cells
represents immunosuppressant failure.
To test my hypothesis, I plan to use cryopreserved samples from a sensitized non-human primate
model of transplantation. I will study samples A) during the process of sensitization and B) during a
desensitization protocol. I will use flow cytometry and T cell receptor sequencing to characterize how Tfh2
& Tfh17 cells proliferate during sensitization. I will determine if differences exist between the circulating
and lymph node compartment of these cells. Cytokine release and Ig production assays will be used to
observe how Tfh cells functionally respond to desensitization protocols; TCR sequencing will confirm Tfh2
& Tfh17 depletion following desensitization with reconstitution proceeding graft rejection.
In summary, I believe Tfh2 & Tfh17 cells play a critical role in antibody formation and the resultant
AMR. If my hypothesis is correct, reconstitution of these population could represent immunosuppressant
failure and these cells could serve as a potential target for future immunosuppressive protocols.

Public health relevance
PROJECT NARRATIVE Kidney transplantation is the preferred treatment for end-stage renal disease and is superior in cost, outcomes, complications, and patient satisfaction compared to hemodialysis ; long-term success is limited by antibody-mediated rejection. We lack an understanding of the role T follicular helper cell subsets play in antibody formation and antibody-mediated rejection. This project will examine transplant-pertinent T follicular helper cell subsets to: 1) define their role in sensitization and recipient antibody formation to donor allograft 2) determine if these cells are potential targets to prevent antibody formation and improve outcomes.